Bacterial and host response to biofilm dispersal in wound infections

Project Summary
Most chronic infections are due to the presence of biofilm, which makes microbes exceptionally recalcitrant to
treatment. In soft tissue infections, such as chronic wounds, even a combination of repeated debridement and
antimicrobial/antibiotic treatment frequently fails to remove the biofilm. Consequently, chronic wound infections
are considered a major global health problem with over 6.5 million people suffering from them each year just in
the U.S. To combat this healthcare challenge, researchers are pursuing the therapeutic use of biofilm dispersal
agents, which if effective can induce microbes to leave the safety of the biofilm, increasing their susceptibility to
conventional antibiotics, antimicrobials and the immune response. However, little is known about the effects of
dispersal on bacteria or the host. In this project we will investigate the risk versus reward of using biofilm dispersal
to treat wound infections. Using a mouse wound model, we will determine the effects of
four
types of dispersal
strategies on Pseudomonas aeruginosa, which is common cause of wound infections and a model organism for
biofilm studies. We will determine if either active or passive in vivo dispersal strategies induce phenotypic or
transcriptomic changes in P. aeruginosa that could make it more threatening to the host. We will also characterize
the host response after active and passive dispersal of P. aeruginosa from mouse wounds by performing a
temporal analysis of clinical biomarkers, including blood physiological and biochemical indices, cytokines, and
assessing whether dispersed P. aeruginosa enters the bloodstream by inducing vascular damage that leads to
increased vascular permeability. We expect these experiments to reveal the pathophysiological mechanisms of
dispersal-mediated sepsis and shed new light on how P. aeruginosa responds to different types of dispersal
agents. On a basic science level, we will learn more about how biofilm and dispersal relate to infection and how
P. aeruginosa causes bacteremia. This investigation will also provide medically translational information for
therapeutic development, including potential hazards to be expected or overcome by dispersing bacteria in vivo.

Public health relevance
Project Narrative Most chronic wound infections are due to the presence of biofilm, which makes the microbes causing the infection exceptionally difficult to kill. In order to combat this healthcare challenge, researchers are pursuing biofilm dispersal agents, which can induce microbes to leave the safety of the protective biofilm and become more susceptible to killing by antibiotics. In this project we will investigate the risk versus reward of using biofilm dispersal as a way to treat wound infections.